Radiation Biodosimetry using Gene Expression Signatures

Project 2 Summary
Project 2 addresses transcriptomic signatures of radiation exposure and injury in the following themes:
Beyond Simple Exposures: Gene expression signatures will be tested for reconstruction of dose in
complex exposure scenarios that mimic those expected to be encountered in an actual radiation / nuclear
event, such as a ground-burst detonation of an improvised nuclear device in an urban area. In such an event,
exposures will be complicated by the very high dose rate of exposure during the initial flash, decreasing dose
rate from fallout, and the presence of neutrons and partial shielding determined in part by the urban
architecture. Unique exposure facilities will be used to mimic these realistic scenarios and to test dose
reconstruction using a reference transcriptomic signature. Signature genes will be replaced or added to
improve both dose reconstruction performance and characterization of complex exposures.
Beyond Dose: To address the late effects of radiation, another transcriptomic signature has been
developed that can predict death or survival following photon-induced pneumonitis. The impact of mixed
neutron+photon exposures on such lung injury is not well known, however, and will now be characterized, with
the outcome-predictive transcriptomic signature being tested for mixed neutron+photon exposures. The
contribution of senescent cells to the development of pneumonitis and the expression of outcome predictive
genes after photon or neutron+photon exposures will also be evaluated.
Beyond Model Systems: Biodosimetry is ultimately intended for use with in-vivo human exposures, but
assay development typically uses either ex-vivo irradiated human blood or in-vivo irradiated mice or non-
human primates. A major gap in knowledge thus exists, regarding the application of results from experimental
models to humans. Direct comparison of ex-vivo and in-vivo exposures to both photons and neutrons will be
conducted in both non-human primate and mouse models, and the accuracy of dose reconstruction using
transcriptomic signatures will be assessed. These studies will include juvenile, adult, and old mice, to quantify
the possible impact of age on dose reconstruction, and to test if the ex-vivo model reflects age-specific
differences seen in vivo. Non-human primate to human extrapolation will also be addressed, comparing results
from ex-vivo neutron irradiated non-human primate and human blood samples to develop and test cross-
species conversion approaches for dose reconstruction after neutron exposure.
Optimized Biomarker Integration: Data from the biodosimetry approaches of all three Projects (Project 1:
cytogenetics, Project 2: gene expression, Project 3: metabolomics) will be analyzed in conjunction to determine
the relative strengths of each approach, and to develop decision trees for guiding the application of
biodosimetry methodologies in real world situations.